Adapting intake procedures to improve treatment delivery in addiction treatment

This Mentored Patient-Oriented Research Career Development application (K23) will provide protected time for
Dr. Margo Hurlocker to become an independent researcher at the University of New Mexico (UNM) and Center
on Alcohol, Substance use, And Addictions (CASAA). Her goal is to develop the expertise to integrate and test
implementation strategies within clinical trial designs to improve the treatment delivery system and client
engagement in addiction and other behavioral treatment programs. As a first step in developing expertise in
addiction implementation science, the candidate proposes an original, mentored research study focused on
replacing the comprehensive assessment with an evidence-based intervention (Motivational Interviewing [MI])
during a client’s initial contact with an addiction treatment program to improve client entry, engagement and
retention. Addiction treatment programs have some of the highest premature dropout rates and approximately
44% of clients drop out after the intake assessment. The assessment-based intake may contribute to the high
rates of client dropout given the emphasis on gathering information rather than exploring client reasons for
seeking treatment. This study builds on a large body of literature supporting MI as a prelude to other evidence-
based treatments to facilitate treatment engagement, by using an effectiveness-implementation hybrid design
to (1) examine the clinical utility of MI at intake on client’s entry and engagement in treatment, and (2) use a
mixed-methods approach to evaluate treatment personnel’s’ perspectives of implementation feasibility. Also,
in-treatment factors (readiness to change; working alliance) are examined as putative mechanisms of
engagement-related outcomes given pre-treatment factors tend to account for a small amount of variance in
client dropout. This mentored study will offer hands-on training to help the candidate develop the expertise to
establish her own independent addiction research program. With the guidance of her mentorship team, Dr.
Hurlocker’s training plan and mentored study are integrated and will promote a comprehensive skill set in the
following areas: (1) conducting clinical effectiveness research in addiction treatment programs (Theresa
Moyers & Barbara McCrady; UNM), (2) implementation theory and application (Geoffrey Curran; UAMS &
Kamilla Venner; UNM), (3) implementation process evaluations (Theresa Moyers; UNM & Geoffrey Curran;
UAMS), and (4) advanced quantitative analyses of client and provider data (Katie Witkiewitz; UNM). All
mentors will also assist Dr. Hurlocker in grant preparations and submissions throughout the award period. In
addition to training at CASAA, Dr. Hurlocker will complete substantive coursework with the Institute for
Implementation Science Scholars at Washington University in St. Louis and advanced quantitative coursework
at UNM. Collectively, Dr. Hurlocker’s training goals and mentored study are in line with NIDA’s attention to 1)
the development of innovative methods to improve the healthcare delivery system, and 2) the identification of
in-treatment mechanisms that can promote patient engagement (e.g., PAR-18-007).

Public health relevance
Project Narrative The high rates of premature dropout in addiction treatment programs prevents clients with substance use disorders from receiving and fully benefiting from the wealth of evidence-based treatments available. While the assessment-based approach used during a client’s initial contact with a treatment program offers important information for regulatory agencies, gathering information rather than exploring client reasons for treatment may influence a client’s decision to return to treatment. This patient-oriented career development award will provide the candidate with mentorship and hands-on training in order to examine (1) the clinical utility of a stand-alone motivational interviewing intervention on client engagement, (2) the extent to which in-treatment factors explain engagement-related outcomes, and (3) feedback from treatment personnel on the feasibility, facilitating factors, and barriers to implementing MI at intake in addiction treatment programs.